Peptide Autoinducers of Staphylococcal Pathogenicity

A research program will be undertaken to study agr signal transduction in the commensal pathogen, Staphylococcus aureus. The accessory gene regulator (agr) locus found in all staphylococci encodes a quorum sensing (QS) circuit that controls the expression of virulence and other accessory genes. It consists of two oppositely oriented transcriptional units, of which one encodes four proteins, AgrBDCA, involved in production and sensing of an autoinducer peptide (AIP), and the other encodes a regulatory RNA that is the effector of target gene regulation. The finding that staphylococcal virulence can be inhibited through antagonism of this QS pathway has fueled tremendous interest in understanding the detailed mechanisms at play throughout the circuit. Building on recent breakthroughs that have allowed us to reconstitute much as the quorum sensing circuit using purified components, we propose to integrate chemical, biochemical, biophysical and genetic tools for the purpose of obtaining a deeper understanding into the molecular processes underlying the production and sensing of the autoinducer peptide (AIP) pheromone that is central to agr regulation. The program will move forward in three directions: Aim 1, identifying the key missing players in AIP biosynthesis; Aim 2, understanding how agonism and antagonism of the QS system relates to newly discovered conformational changes in the AIP receptor, AgrC, and; Aim 3, identifying novel modulators of agr through sophisticated target-based screens. These studies will lay the groundwork for the development of therapeutic strategies targeting agr, but also contribute to a fundamental understanding of QS systems of this type, which are pervasive in the low-GC bacterial phylum, Firmicutes.

Public health relevance
Staphylococcus aureus (S. aureus) is an opportunistic pathogen capable of invading mucous membranes or soft tissue; once invasion occurs, the bacterium deploys a diverse arsenal of virulence factors to evade the host immune system and to facilitate spread of the infection in the host environment. A research program will be undertaken to study the central quorum sensing (QS) circuit, termed agr, which regulates the onset of virulence as a function of bacterial population size. Building on recent breakthroughs that have allowed us to reconstitute much of the circuit using purified components, we propose to integrate chemical, biochemical, biophysical and genetic tools to gain a deeper understanding into the molecular processes underlying agr regulation; these studies will provide fundamental insights into how a QS circuit such as agr operates at the molecular level and will lay the foundation for the development of new strategies for treating Staphylococcus aureus infections.